Mechanism and therapeutic opportunities of targeting the Tudor domain

PROJECT SUMMARY/ABSTRACT
MLL-rearranged (MLL-r) leukemias account for 5-10% of human acute leukemia and is associated with
poor prognosis. The unmet clinical needs and the lack of an effective targeted therapy to the MLL-r
leukemias emphasize the need for novel regimens. Recent cancer epigenetics studies discovered a central
role for the histone H3 lysine 79 (H3K79) methyltransferase DOT1L in MLL-r leukemogenesis. Important
clinical responses have been noted with DOT1L inhibitor treatment as a single agent, however, it is expected
that combination treatments will be necessary.
Our preliminary studies based on a Tudor domain focused CRISPR screen in MLL-r leukemia identified
SGF29 as a novel vulnerability in MLL-r leukemia. The objective of this application is to determine the critical
epigenetic mechanisms that mediate the availability of KAT2A/B to maintain H3K9ac and oncogene expression
in MLL-r leukemia. Our central hypothesis is that SGF29, an H3K4me3 reader protein, mediates recruitment
of KAT2A/B to maintain histone H3K9ac and MYC oncogenic program in MLL-r leukemia. We will dissect the
SGF29-mediated epigenetic mechanisms (Aim 1) and investigate the efficacy of SGF29 targeting (alone or in
combination with DOT1L inhibition) as a novel therapy in MLL-r leukemia (Aim 2).
This study is innovative because (1) it introduces a novel concept of simultaneously targeting multiple
components of an epigenetic network to efficiently suppress the cancer programs, and (2) it establishes a
brand new genetic screen approach for a sub-protein level functional pocket and drug discovery. The impact
of this research will be of significance because (1) it immediately provides novel therapeutic opportunities
against the difficult-to-treat MLL-r leukemias, and (2) it will help identify novel functional elements in
epigenetic regulators for future pharmaceutical targeting.

Public health relevance
PROJECT NARRATIVE MLL-rearrangement (MLL-r) affects about 10% acute leukemia patients and is associated with poor prognosis. This proposal has immediate clinical relevance in developing a more advanced treatment to MLL-r leukemias, and will contribute to a broader understanding of how the dynamic epigenetic networks control oncogene expression in cancers and therapeutic responses. The technology developed in this project will facilitate functional domain discovery for future targeted therapies.